Cortical Neuronal Vulnerability in Parkinson's Disease

Abstract
Parkinson’s disease (PD) is a debilitating, progressive neurological disease characterized by accumulation of
misfolded α-synuclein (referred to as Lewy pathology) that progresses throughout the brain and the loss of
patient motor function. No disease modifying treatments are available, and therefore these patients continue to
deteriorate throughout the disease. Therefore, this project intends to determine which neurons are vulnerable
and resilient in PD, and what cellular dysfunction(s) they experience. This training intends to 1.) develop and
refine skills in bioinformatics, genomics, and wet-lab techniques 2.) apply these developed skills to lead the
independent research project outlined in this proposal 3.) enhance communication and presentation skills to
ensure a successful transition to the next step in a career focused on neurodegenerative disease research. My
previous work has determined that Lewy pathology bearing cells experience specific cellular dysfunctions
which leads to activation of cell-death pathways. In addition, I have identified that specific neuron types are
vulnerable (Layer 5 Intratelencephalic Neurons) and resilient (Layer 5 Pyramidal Tract Neurons) to Lewy
pathology in the PD cortex. Expanding on my previous work, I will (Aim 1) identify resilient neurons and
pathologic signatures in the PD cortex at single cell resolution using spatial transcriptomics. Through this, I will
define the neuronal response to aggregates as they mature within individual neurons. Additionally, I will (Aim 2)
determine the spatiotemporal basis of resilience to α-synuclein pathology. In this aim, I will determine whether
disease stage (time) and/or symptom specific (brain region) treatments are targetable or determine if more
universal disease modifying treatments are possible due to overlap in cellular dysfunctions across brain
regions and time points. In addressing these two aims, we gain understanding of the stages of molecular
response to Lewy pathology as aggregates mature, as disease progresses, and in multiple brain regions and
therefore gain understanding of the mechanisms of resilience to Lewy pathology. In addition, we identify
pathways and specific genes to target for disease modifying treatment of Parkinson’s disease. Finally, the
proposed training goals and objectives provide an excellent foundation in the requisite skills and expertise
necessary for a successful future career in neurodegenerative disease research.

Public health relevance
Project Narrative Parkinson’s disease is a debilitating neurodegenerative disorder which ~1.3 million people currently suffer from with no disease modifying treatment available. This proposal intends to determine molecular processes involved in the resilience and vulnerability of neurons as Lewy pathology matures within neurons, as disease progresses, and across brain regions. Through this, we identify pathways and genes which can be targeted to develop disease modifying treatments.